INVESTIGATOR DEVELOPMENT CORE

The mission of the Investigator Development Core (IDC) is to develop future leaders in diversity aging research, focused in the area of CHIME's theme. Developing, Adapting and Evaluating Interventions to Improve the Health of Minority Elders. The IDC will provide mentoring, training and research support for junior and mid-career investigators to help them develop and sustain careers in diversity aging social, behavioral, and clinical research. The specific aims of the IDC are to: 1) Identify and recruit candidates who have demonstrated research potential and specific interest in diversity aging research that is consistent with CHIME'S research theme and/or advances the field of measurement among minority elders; 2) Select at least 3 outstanding junior and midcareer faculty to receive 1-year pilot studies with matching funds from the UCLA CTSI to fund pilot studies at a level of $40,000; 3) Provide intensive individual mentorship and a broad array of educational and infrastructural resources from the RCMAR, UCLA CTSI, and other NIA funded centers to enable CHIME Scholars to successfully complete their research, present and publish their work and ultimately obtain independent research funding; 4) Closely monitor the progress of CHIME Scholars in partnership with the National Coordinating Center using a standardized program of progress reports, mentorship committee meetings and research progress review by the CHIME Executive Committee (EC). The proposed pilot investigators for the first year include: 1) Dr. Luisa Blanco, a Latina economist who aims to use existing data and focus groups to determine factors explaining non-participation in the financial sector (e.g., no use of banking services) among older Latinos and African Americans and assess the impact of financial exclusion on health. This work will inform interventions to improve health among these populations by improving access to financial institutions; 2) Dr. Sarah Choi, a Korean-American nurse who aims to conduct focus groups to refine and assess feasibility of a diabetes self-care program tailored for Korean immigrant older adults through cultural adaptation and integration of spousal support. This work will lead to further testing an intervention to improve self-care of older diabetic Korean immigrants; 3) Dr. Homero del Pino, a Latino social scientist who aims to conduct interviews to understand the nature of family support among those in recovery from alcohol use disorders and whether family support differs among gay and heterosexual and younger and older Latino men. This work will provide the basis for developing alcohol use disorders prevention and intervention programs for older Latino men.

Public health relevance
The Investigator Development Core (IDC) is focused on developing future leaders in aging research with racial/ethnic minorities, particularly focused on the Center's theme, which is developing, adapting and evaluating interventions to improve the health of minority elders. The IDC will mentor, train and provide research support for junior and mid-career researchers to help them develop and sustain careers in social, behavioral, and clinical research on issues that affect older racial/ethnic minority populations.